Admin_Core

PROJECT SUMMARY/ABSTRACT (ADMINISTRATIVE CORE) The objective of the Administrative Core of the University of Pennsylvania Telehealth Research Center of Excellence in Cancer Care (Penn TRACE) is to ensure that the impact of the Center is greater than the sum of its parts. The Administrative Core will accomplish this objective by maximizing collaboration and synergy across the
Research and Methods Core, Clinical Practice Network, and Pragmatic Trial. The Center’s cohesive organizing framework addresses the fundamental question of how to leverage insights from communication science and behavioral economics to design and test innovative telehealth strategies for care delivery to improve effectiveness and access across the cancer care continuum, with an
emphasis on understanding mechanisms of action. The Administrative Core will provide overarching strategic, operational, and scientific oversight to achieve this organizing framework. The specific aims
of the Administrative Core are to: 1) Provide essential leadership and integration of all Penn TRACE activities; 2) Create interdisciplinary research capacity and collaborations; 3) Coordinate
communication and dissemination of research findings, evidence-based telehealth strategies, care delivery models, and other resources to scientific audiences and other relevant partners; and 4)
Monitor and evaluate Penn TRACE progress and leverage findings to inform iterative refinement of Penn TRACE activities and plans for future research. Completion of these aims will create a culture of
exceptional interdisciplinary science and ensure success by stimulating and guiding new methodological advancements, building capacity for cancer care delivery research, and generating a
robust evidence base for patient-centered, sustainable telehealth models of care at Penn and nationally. The Administrative Core leadership will ensure that Penn TRACE fulfills the National Cancer
Institute’s vision to advance a national telehealth research agenda focused on improving cancer related care and outcomes across the cancer care continuum in a rapidly changing health care, policy,
technology, and communication environment.

Public health relevance
The University of Pennsylvania Telehealth Research Center of Excellence in Cancer Care (Penn TRACE) will apply insights from communication science and behavioral economics to design and test synchronous telehealth strategies, supported by asynchronous elements, to improve effectiveness and access across the cancer care continuum, with an emphasis on understanding mechanisms of action. We focus on lung cancer as an exemplary model for telehealth across the care continuum, from screening to treatment to survivorship. Penn TRACE will produce new fundamental knowledge with the potential to transform cancer care delivery and outcomes for millions of Americans.